Research Education Core

Research Education Core
Key Personnel:
Lauren M. Aleksunes, Pharm.D., Ph.D., Core Lead
Debra L. Laskin, Ph.D., Co-Lead
Diane E. Heck, Ph.D., Collaborator
Joshua P. Gray, Ph.D., Collaborator
Ned Heindel, Ph.D., Collaborator
Ray Rancourt, Ph.D., Collaborator
Core Summary/Abstract
The Rutgers CounterACT Center has established a comprehensive, multidisciplinary Research Education Core
directed at high school students, undergraduates, professional and graduate students, postdoctoral trainees
and new and established investigators. The primary functions of the Research Education Core are to 1)
provide multidisciplinary short-term education for technicians, professional or graduate students, postdoctoral
trainees, and/or established investigators, within and beyond the CounterACT Center, 2) increase the number
and capabilities of a diverse toxicological workforce addressing chemical threats, 3) evaluate and disseminate
CounterACT teaching materials, trainee accomplishments, and assessment metrics to other universities and
biomedical researchers. These functions are achieved through seminars, symposia, coursework, remote
education programs, thesis projects, research fellowships, and directed laboratory modules. Training in the
responsible conduct of research and rigor and reproducibility is integrated into short-term and long-term
training programs hosted by the Core. The leadership team of the Education Core is comprised of faculty
members spanning 4 institutions who have expertise in mentoring, training program management, toxicology
education, online learning, and development of curricula. The Education Core draws upon the resources,
infrastructure, and expertise of faculty appointed across the four academic institutions and draws strength from
additional institutional grants including UL1, T32, P30, and R25 NIH grants from NIEHS and NCATS. In the
prior funding period, we had outstanding success in recruiting trainees from underrepresented backgrounds to
Core programs. By building a pipeline of training activities over the past 10 years, we have retained talented
students from diverse groups within the field of toxicology. In the renewal application, we propose to enhance
training opportunities for our current trainee pool, expand the training of CounterACT members in team science
and communicating science, and host hands-on workshops and bootcamps to the broader applied toxicology
community. Emphasis will also be placed on iterative assessment of activities using a Logic Model,
dissemination of program curricula and outcomes, and tracking of participants in the Education Core. The
Education Core has made tremendous achievements in the prior funding period that will be augmented and
expanded over the next 5 years.